Pathogenic mechanisms in post-bereavement psychopathology: Contributions of gene-environment interplay, psychosocial factors, and cognitive ability in two population-based cohorts

PROJECT SUMMARY/ABSTRACT
Over 75% of all adolescents will experience the death of a close friend by the time they reach college age, and
3 million children will experience the death of a parent by the age of 18 (or the equivalent of one child in every
classroom). Childhood bereavement increases risk for psychopathology, which itself exerts negative effects
across the lifespan. Available clinical trial data provide preliminary evidence that risk of post-exposure
psychopathology can be significantly reduced by preventative interventions. However, further development of
preventative interventions is hampered by limited understanding of temporal patterns of post-loss
psychopathology, as well as the joint effects of genetic liability, developmental timing, cognitive ability,
psychosocial variables, and environmental exposures. This application describes a sequence of mentored
training and research activities that will address these limitations by preparing me to lead integrative,
developmentally-informed, consortium-based research to discover powerful new approaches to preventing
post-exposure psychopathology, consistent with NIMH strategic plans 1.2 and 2.1. The overall objective for this
K23 application, which is the next step in pursuit of my long-term goal, is to augment my background in clinical
psychology and psychosocial factors with mentored training in lifespan psychiatric epidemiology, polygenic
epidemiology and pooled consortium science using two carefully selected population-based longitudinal
cohorts, the Avon Longitudinal Study of Parents and Children (ALSPAC; n=14,541) and Generation R (GR;
n=9,778). My overarching hypotheses is that identifying pathogenic mechanisms that influence the risk for
post-bereavement psychopathology in youth will ultimately inform effective preventative and treatment
interventions that reduce the burden of post-exposure psychopathology. The proposed research strategy uses
a biopsychosocial model that thematically links three Specific Aims: (Aim 1) to characterize the onset and
discrete heteronomous patterns of post-loss psychopathology; (Aim 2) to understand the influence of biological
(sex, gender), psychosocial (social support, parental relationships) and cognitive factors (cognitive ability) on
post-bereavement psychopathology; and (Aim 3) to investigate whether polygenic risk for depression interacts
with bereavement to increase risk for post-bereavement psychopathology. The rationale for the proposed
research is that considering the joint effects of biological, psychosocial, and cognitive factors will yield a more
robust knowledge of who is most vulnerable to post-loss psychopathology, thus resulting in greater ability to
prevent adverse outcomes. My success will build critical skills for research independence and generate pilot
findings to submit an R01 in Year 4 of this award that focuses on novel and powerful new approaches to
understanding and preventing post-exposure psychopathology.

Public health relevance
PROJECT NARRATIVE Bereavement is associated with increased risk for psychopathology, even though available clinical trial data suggest that post-exposure psychopathology can be significantly reduced by preventative interventions. The proposed sequence of mentored training and research activities is designed to provide the skills necessary to lead integrative, developmentally-informed consortium-based research to discover powerful new approaches to preventing post-exposure psychopathology. Specific biopsychosocial investigations in longitudinal patterning, mechanisms, and gene-environment interplay will build knowledge of pathogenic processes in post-exposure psychopathology, and point to candidate preventative and intervention studies that will be the focus of the forthcoming R01 application.